ONI NanoImager

PROJECT ABSTRACT
Children’s Hospital Los Angeles (CHLA), an affiliate of the University of Southern California (USC), requests
funds to purchase a Nanoimager (ONI, Inc.) for the Extracellular Vesicle (EV) Core Facility of The Saban
Research Institute (TSRI). EVs and their artificial counterpart, lipid nanoparticles (LNPs), represent a
breakthrough in several therapeutic applications including, but not limited to, regenerative medicine, vaccine
development, and biomarker discovery. The successful therapeutic application of EVs and LNPs will require
overcoming several technical and quality control challenges inherent to their very nature. Because of their
small size, their purification requires advanced techniques that do not guarantee their structural integrity and
reproducible purity. Visualization of their structure and molecular makeup has historically been limited to costly,
low throughput, and technically challenging electron microscopy techniques. The ONI Nanoimager utilizes
dSTORM (direct Stochastic Optical Reconstruction Microscopy), a Single-Molecule Localization Microscopy
technique (SMLM), to resolve EVs and nanostructures at the single-molecule level with a resolution of 20nm.
This allows the revealing of the spatial structure of single particles, including their molecular determinants. The
Nanoimager will enable the researchers to develop quality control and reproducibility assays by simultaneously
visualizing the structural integrity of the particles and the presence of markers that support the mode of action
of novel therapeutics. There is a strong rationale for the request. First, the current instrumentation housed at
the EV Core does not allow for an in-depth analysis of the particles’ quality and heterogeneity, limiting our
analytical capabilities to the sizing and counting by Nanoparticle Tracking Analysis (Nanosight NS300) and to
the detection of the cargo by low-resolution immunophenotyping of single EVs captured on a chip (ExoView
R100, limited to EVs). Second, by instituting the first core lab in the country dedicated to EV research, CHLA
has shown its commitment to supporting researchers focused on the investigation and development of EV and
LNP-based therapeutics. After detailed testing of three dSTORM imaging instruments (ONI Nanoimager,
AbbeLight, Bruker Vutara), we determined that the Nanoimager is optimal for the inclusion in a core lab at
CHLA because of its integrated specimen preparation and analysis capabilities, and the demonstrated
commitment of ONI to the development of automated workflows for EV and nanoparticle research. Lastly, the
EV Core has built a solid user base of NIH-funded and other CHLA and USC researchers that will immediately
benefit from this instrument. The ONI Nanoimager will be fully supported financially by CHLA and managed by
Ph.D.-level personnel, with the direct assistance of the Cellular Imaging Core. This instrument will significantly
benefit users at CHLA and beyond by allowing us to characterize the composition of EVs and meet the long-
term objective of deciphering the mechanisms of pediatric disease.

Public health relevance
PROJECT NARRATIVE The ONI Nanoimager, a versatile next-generation extracellular vesicle analyzer, will allow investigators at CHLA to visualize extracellular vesicles (EVs) and lipid nanoparticles (LNPs) at their molecular level in unprecedented detail. This will allow a deeper understanding of the biology of EVs, providing new insights into the mechanisms that guide typical human development, the factors that cause childhood diseases, and the interventions that address cellular and organ pathophysiology. Furthermore, the investigators will be able to utilize the Nanoimager to develop quality control assays for manufacturing EVs and LNPs for therapeutic applications.